Mesoscale and Nanoscale Technologies Integrated by Structures for DNA Repair Complexes (MANTIS-DRC)

PROJECT SUMMARY/ABSTRACT
Cancer is linked to every human DNA repair (DR) pathway. Genomic instability, which results from DR defects,
is a cancer hallmark. Due to cancer cell susceptibilities from oncogenic stress and frequent DR defects, DNA
damaging approaches are widely used successful cancer therapies. Yet, cancers may escape these therapies.
Furthermore, they can cause toxicities, aging, and secondary cancers making knowledge to combat
therapeutic resistance and to design advanced therapies important. In fact, DNA damage effects depend upon
poorly understood dynamic DR complexes that are also a target for precision oncology. This R35 renewal
application for Mesoscale and Nanoscale Technologies Integrated by Structures for DNA Repair Complexes
(MANTIS-DRC) will focus on structures, mechanisms, and cancer cell biology impacts from exemplary systems
addressing three critical knowledge gaps: 1) RNA alkylation response impacts on cancer cells, 2) DDR
adaptors and complexes determining repair pathway choice at replication forks and DNA double-strand breaks
(DSBs), and 3) mitochondrial sensing and response to PARylation and resulting changes in NADH levels. We
will harness AlphaFold structure predictions for experimental structures including functional dynamicity and
combine them with data analyses from whole genome studies (WGS) to determine how cancer genomes
respond to damage, develop genome instability, and elaborate synthetic lethality for inhibitors to DDR.
Alkylation therapies are widely used, but their damage to RNA, which is both more exposed to this damage
and is roughly 10-fold higher than DNA, has unknown cancer cell impacts. Knowledge of DR pathway choice at
DSBs and stalled forks remains incomplete. Although energy production and mitochondrial complex 1 is a
cancer drug target how mitochondria respond to DNA damage and parylation, which lowers NADH levels, is
enigmatic. Based upon his current R35 progress, Prof. Tainer is poised to efficiently test and define
mechanisms underlying the outcomes to RNA alkylation responses, repair at DSBs and replication forks, and
the mitochondrial response to high NADH use in DDR. With R35 support, we developed time-resolved X-ray
scattering and its integration with atomic detail for conformations and assemblies that help link structures to
phenotypes and biological outcomes. To elucidate how dynamic multi-functional DDR complexes orchestrate
cellular responses to RNA damage, DNA damage at replication forks and breaks, and NADH levels, we will
map their dynamic conformations and kinetics with systematic analyses. Rather than correlating data sets, we
will integrate quantitative measurements to collapse complex data into unifying insights and actionable
knowledge. Leveraging cutting-edge clinical information at MD Anderson will enable testing the relevance and
impact of MANTIS-DRC predictions on patient databases. Collective results will produce objective mechanistic
measurements from molecules to cells to design dissection-of-function mutations and inhibitor tools and to
predict DR outcomes and their links to innate immune responses for cancer biology and medicine.

Public health relevance
NARRATIVE As shown by mutations in DNA damage responses and cancer cell biology, DNA damage causes cancer, is used to treat cancer, and acts in side effects to cancer treatment. Yet, DNA damage effects depend upon incompletely understood dynamic DNA repair complexes (DRC) that are also a target for precision oncology and advanced treatments including immune therapies. To advance cancer medicine by addressing critical knowledge gaps, our MANTIS-DRC project will provide foundational data on dynamic multi-functional repair complexes and their connections to cancer biology and patient outcomes.